Targeting the USP2-POU2F3 signaling pathway for small cell lung cancer (SCLC-P) treatment

Project Summary/Abstract:
Small cell lung cancer (SCLC) is a highly aggressive form of neuroendocrine carcinoma,
accounting for approximately 15% of all lung cancers. SCLC is a heterogeneous disease, broadly
categorized into four molecular subtypes: neuroendocrine subtypes driven by ASCL1 (60%) and
NEUROD1 (20%), and non-neuroendocrine subtypes marked by the POU family transcription
factor POU2F3 (10-12%) or an inflammatory subtype (10%). More importantly, the high
expression of ASCL1, NEUROD1, and POU2F3 is not only a stratifying biomarker, but also
presents promising therapeutic opportunities, as these transcription factors represent selective
dependencies in SCLC, depletion of which leads to cell death for the particular subtype.
Specifically, the POU2F3-positive small cell lung cancer subtype (SCLC-P) is heavily reliant on
POU2F3 for survival and growth. However, the upstream regulatory pathways controlling
POU2F3 expression, particularly through post-translational modifications, remain largely
unexplored. Thus, elucidating the molecular mechanisms that regulate POU2F3 protein
homeostasis and identifying strategies to reduce its protein abundance may open new therapeutic
avenues for SCLC-P. In this proposal, I have accumulated preliminary studies to identify APCCDC20
as a potential E3 ubiquitin ligase that promotes POU2F3 proteasomal degradation through
mediating plolyubiquitination of the POU2F3 oncoprotein. Conversely, USP2 has been identified
as a potential deubiquitinase that stabilizes POU2F3 by removing its ubiquitin chains. Importantly,
USP2 inhibitors have demonstrated the ability to induce significant degradation of POU2F3 and
suppress cell growth in SCLC-P settings. In the first aim of this study, I will explore the molecular
mechanism and the physiological role of APCCDC20 in regulating POU2F3 ubiquitination and
protein stability in SCLC-P (Aim #1). In the second aim, I will assess the critical role of USP2 in
stabilizing POU2F3 oncoprotein and evaluate its potential as a therapeutic target in SCLC-P (Aim
#2). Collectively, these proposed studies will allow me to reveal a dynamic regulatory mechanism
for POU2F3 protein homeostasis involving the E3 ligase CDC20 and the deubiquitinase USP2,
with clinical implications for retarding SCLC-P tumorigenesis in vivo. This study will also provide
a strong rationale for targeting USP2 with specific inhibitors as a potential therapeutic strategy for
treating SCLC-P patients in future clinic practice.

Public health relevance
Project narrative: Given that the POU2F3-positive subtype of small cell lung cancer (SCLC-P) relies heavily on POU2F3 for survival and growth, while the upstream signaling pathways that regulate POU2F3, particularly through post- translational modifications remain largely unexplored. This proposal seeks to characterize the physiological roles of the E3 ubiquitin ligase APCCDC20 and the deubiquitinase USP2 in modulating POU2F3 ubiquitination and stability, and how these processes influence SCLC-P tumorigenesis. Successful completion of the proposed studies will provide the molecular insights and the rationale for the usage of USP2 inhibitors as a novel therapeutic strategy for treating SCLC-P patients.